Intrinsic B cell epigenetic regulation of antibody and autoantibody responses by Sirt1

PROJECT SUMMARY
We want to unveil novel fundamental B cell-intrinsic epigenetic mechanisms that maintain B cell homeostasis
and inform B cell processes critical to the antibody response to exogenous antigens (e.g., viruses, bacteria)
and self-antigens (e.g., dsDNA, RNPs in systemic lupus). As we have shown in the first cycle of this grant,
epigenetic mechanisms interact with genetic programs to modulate AID (encoded by AICDA/Aicda) expression,
critical for SHM/CSR. Indeed, Zn2+-dependent Class I, II and IV HDACs promote AID induction and SHM/CSR
in a B cell-intrinsic fashion. AID induction is dampened by Class I, II and IV HDAC inhibitors, such as short-
chain fatty acids produced by gut microbiota via processing of dietary fibers, through upregulation of select
microRNAs that target AICDA/Aicda 3’UTR, leading to abrogation of antibody/autoantibody responses.
Prompted by our most recent and compelling findings on Sirt1, a NAD+-dependent Class III HDAC and
metabolic sensor implicated in aging, cancer and diabetes, we hypothesize that this Sirtuin dampens AID (a
role opposite to that of Class I, II and IV HDACs) in a B cell-intrinsic fashion, and regulation of Sirt1 expression
or activity effectively modulates SHM/CSR and antibody/autoantibody responses. As we contend, high Sirt1
levels/activity would effect homeostatic Aicda silencing in resting B cells, the first phase of a tri-phasic
fluctuation of reciprocal Sirt1 and AID expression, as followed by low Sirt1 and high AID in activated B cells
and back to high Sirt1 to low AID in plasma cells and memory B cells. Sirt1 would modulate AID expression
through a three-prong histone and non-histone protein deacetylation. It would also enforce a B cell-intrinsic
metabolic–epigenetic checkpoint of AID upregulation since Sirt1 cofactor NAD+ integrates metabolic cues.
Our strengths in B cell biology, molecular SHM/CSR mechanisms and autoimmunity, as well as our cutting-
edge epigenetic approaches (ChIP-Seq, methylDNA-Seq and ATAC-Seq), new tools in biochemistry (NAD+
biosensor), genetics (Cd19+/Cre-Ert2Sirt16fl/flRosa26fl-STOP-fl-tdTomato and Cd19+/Cre-Ert2Rosa26fl-STOP-fl-Sirt1-IRES-Gfp mice),
imaging (AicdaCreRosa26fl-STOP-fl-luciferase reporter mice), and animal models of human antibody/autoantibody
responses (humanized NSG/cKitW-41J mice) make us uniquely poised to test our hypotheses. Aim1 addresses
human and mouse B cell differentiation stage-specific regulation of Sirt1 expression and NAD+ levels, and
underlying mechanisms, with focus on transcription activator USF1, transcription repressor c-Myb and
microRNAs targeting Sirt1 3’UTR. Aim 2 addresses B cell Sirt1 role in dampening AICDA/Aicda expression
through genetics and/or compounds/metabolites, and defines underlying H3K4Ac, H3K36Ac, Dnmt1 and NF-
kB deacetylation mechanisms; Aim 3 addresses the inhibition of antibody and autoantibody responses by B
cell Sirt1 and Sirt1 activators, and explores Sirt1 activators as therapeutics in systemic lupus. Our highly
significant and innovative experiments will provide novel mechanistic insights into B cell epigenetics and
immunoregulation, and yield metabolic-epigenetic checkpoint modulators as new therapeutics in autoimmunity.!

Public health relevance
PROJECT NARRATIVE Epigenetic marks “interact” with genetic programs to regulate B cell functions, such as immunoglobulin (antibody) gene class switch DNA recombination (CSR), somatic hypermutation (SHM), thereby informing the antibody response; dysregulation of epigenetic mechanisms in B lymphocytes, however, can result in aberrant antibody responses, and would compound genetic susceptibility to mediate autoimmunity, including systemic lupus (SLE), in which heavily mutated and class-switched (mainly IgG) autoantibodies produce widespread tissue and organ injury. This proposal addresses the role of Sirt1 in downregulating antibody and autoantibody responses and underlying mechanisms, with focus on how Sirt1 dampens the expression of AID, which is essential for CSR and SHM. It will also address how the expression and activity of Sirt1 is regulated at different differentiation stages of B cells and by small molecule activators as well as metabolic elements, thereby providing the basis for the development of Sirt1 activators as therapeutics in autoimmune diseases.